Lipidome Remodeling During Development of T1D

Project Summary/Abstract
DESCRIPTION: Lipids are essential cellular components and act as mediators in cell signaling. The function of
lipids is determined by their structures. Dysregulated lipid metabolism is associated with a variety of
pathological conditions, including Type 1 Diabetes (T1D). The levels of lipids cannot be predicted by the
transcripts or proteins. To understand more about the role of lipids in the development of T1D, an important
first step is to directly measure the temporal changes of lipids in an organism that shares similar physiology
with human T1D. Built on our technological advancements in comprehensive global lipidomics, targeted
lipidomic analysis of lipid mediators, isobaric labeling-based multiplexed analysis of intact glycolipids and
determination of C=C unsaturation in intact lipids, in this project, we aim to profile the longitudinal changes of
the nonobese diabetic (NOD) mouse lipidome during different stages of T1D development by accomplishing
the following: 1) in-depth profile and accurately quantify the major lipids in T1D-pertinent tissues using global
lipidomics; 2) use advanced technologies to improve structural resolution, accurately identify and quantify
glycolipids and broadly profile bioactive lipid mediators; and 3) compare lipid expression profiles in different
tissues and characterize lipidome remodeling during different stages of T1D development. Successfully
accomplishing these goals will not only provide invaluable resource to the research community interested in
the role of lipids in the development of T1D, but it will also provide better practices for conducting lipidomics
research in general.

Public health relevance
Narrative PUBLIC HEALTH RELEVANCE: Lipids are a class of biomolecules that are not only a major component of cellular membranes, but they also function as cell signaling mediators. Dysregulated lipid metabolism is associated with Type 1 Diabetes (T1D). Quantitative profiling of lipids in nonobese diabetic mouse – a widely used model organism that shares similar physiology with human T1D, is an important step toward understanding the role of lipids in human T1D development.